Human IgE Antibody Secreting Cells in Blood, Nasal Polyps, and Bone Marrow

Abstract: Allergies affect over one third of the world's population, and the prevalence of asthma is estimated at 300 million patients worldwide 17. In the US alone, asthma prevalence is 8-10% with a subset of 10% who suffer from severe disease. Allergen-specific IgE is a major mediator of severe allergic conditions and asthma exacerbations, but little is understood about the biology of human IgE in these patients. The presence of human IgE long-lived plasma cells is a matter of controversy, since mouse models show little evidence of IgE BM resident plasma cells fueling debate that IgE levels are maintained only by ongoing replenishment from short-lived ASC. In my laboratory, we have identified a new LLPC subset in the human bone marrow (BM) compartment and characterized 5 novel circulating ASC populations. In this application, we will demonstrate the presence of human IgE BM LLPC in allergic patients and understand the cellular origins of allergen-specific IgE responses during acute recall responses (after natural allergen exposures) in blood, bone marrow and nasal polyps.

Public health relevance
Project Narrative: Asthma and allergies affects 300 million worldwide and 60 million Americans with US annual cost of asthma estimated to be near $18 billion. Within that number, 25 million people suffering from asthma (8% in adults, 9% in children) and approximately 60% are due to "allergic asthma". For many who suffer from allergies and allergic asthma, IgE is a main mediator of disease, but little is understood about the cellular origins of human IgE; therefore this grant will characterize the cellular origins of IgE which will likely lead to new targets for novel immune therapeutic approaches and/or rational new indications for already FDA approved immune biologics.